Glutaminase and its neurotoxic link to HAND

? DESCRIPTION (provided by applicant): Despite the effectiveness of antiretroviral therapy, HIV-associated neurocognitive disorders (HAND) that affect HIV infected individuals continue to increase. The prevalence of HAND and incomplete reversal of neurocognitive dysfunctions after antiretroviral therapy has called for novel therapeutic approaches. Among the various pathophysiology of HAND, synaptic dysfunction likely underlies cognitive impairments. Interestingly, brain-specific HIV protein Tat expression in mice mimics key aspects of HAND pathology in the post-cART era, suggesting that Tat may be responsible for the sustained CNS complications in patients receiving cART. Tat is known to cause neuronal injury via excitotoxic mechanisms. Furthermore, HIV-1-infected patients have significantly higher concentrations of glutamate in their plasma and cerebrospinal fluid compared to uninfected controls. Elevated levels of glutamate disrupt normal neural transmission in the brain, contributing to the neuropathogenesis of HIV-1 infection. In the past decade we have established that blocking the activity of glutaminase (GLS), a primary enzyme for the production of glutamate, could alleviate macrophages/microglia (MP) neuroinflammatory and neurotoxic response. We have demonstrated causal effects of innate immune activation and proinflammatory on the GLS function in MP and neurons, respectively. Furthermore, we have observed an intriguing release of GLS by MP and neurons, through unidentified mechanism(s) that could cause neuronal injury. Therefore, in the current proposal, we hypothesize that release of GLS-containing MVs is a critical pathogenic event in HIV-1-mediated neuronal injury and synaptic dysfunction in the hippocampus. Moreover, we hypothesize that blocking aberrantly upregulated/released GLS through GLS inhibitors could have therapeutic effects in HAND. Information will be provided as whether brain-specific overexpression of GLS is sufficient to induce brain inflammation, impair synaptic integrity and cognition in mice, and whether conditional knockout of GLS gene could protect neuronal function in a Tat transgenic mouse model of HAND. Furthermore, novel water-soluble GLS inhibitors will be evaluated for their therapeutic potentials in HAND relevant animal models. The elucidation of the GLS dysregulation and its contribution to pathophysiology of HAND will aid in developing potential novel agents for the treatment of HAND and other neurodegenerative disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Excess glutamate is known to cause synaptic dysfunctions and neuronal injury in HIV-associated neurocognitive disorder (HAND). We will investigate a novel approach to target glutaminase, a primary enzyme for the production of glutamate in the brain, to block excess glutamate production. Inhibition of glutaminase may become a novel strategy to prevent neuronal injury in HAND.